Novel pharmacologic agents in CLL

The goals of the Pharmacology Component of the CLL Cooperative Group are to develop in the laboratory, using model systems and primary CLL cells in vitro, an understanding of the mechanisms of action of agents acting alone and in mechanism-based combinations. This knowledge base will provide rationale for the design of clinical trials that will test hypothesis regarding the actions and interactions of these agents in CLL cells in clinical trials. This will be achieved by employing assays of the pharmacodynamic actions specific to each individual agent, and procedures that are appropriate for characterization of the interactions of agents in combination in CLL cells in the clinical context. The classes of compounds of interest are: 1) Nucleoside Analogs. This class of drugs, particularly fludarabine and cladrabine, has demonstrated major clinical efficacy in CLL. Gemcitabine, a readily metabolized, long-lived pyrimidine nucleoside analog, Clofarabine, 2-chloro-2'-flouro- arabinosyladenine, presently in the final stages of preclinical development, that has favorable pharmacokinetic and pharmacodynamic properties. 2) Inhibitors of Signaling Pathways. New agents, several of which are in clinical trials, that have specificity against components of the cell cycle regulatory pathways have activity against CLL cells in vitro alone and also in combinations. These agents include: Flavopiridol, an inhibitor of cyclin dependent kinases, is already in phase II evaluation, UCN-01, an inhibitor of protein kinase C, and Depsipeptide (FR901228) an inhibitor of cell cycle signaling through MAP kinase. 3) Development of mechanism-base combinations of cytotoxic drugs. We will pursue a strategy that pairs drugs in combination based on the design that the mechanism of action of each component will complementary, thereby resulting in mechanistic synergism and greater cytotoxicity. Our hypothesis is that the indolent nature of CLL limits the activity of these agents, but the process of DNA repair offers an opportunity for the nucleoside analogs to be incorporated into DNA repair patches. Thus, the essence of this project is to develop for combinations in CLL cells during therapy as approaches for validating and ultimately for developing new therapeutics for this disease.